Substrates and functions of the Sideroflexin mitochondrial transporter family

7. PROJECT SUMMARY/ABSTRACT
Metabolic flux generates energy and building blocks to fuel the many processes occurring in cells and
organisms. Mitochondria are central organelles in both catabolic and anabolic cellular metabolism, a function
for which they require efficient exchange of metabolites with the rest of the cell. Mitochondrial transporters
facilitating metabolite exchange across the inner mitochondrial membrane thus play a key role in metabolism
and physiology. Alterations in mitochondrial transporters have been linked to diseases including cancer,
however, the identities and functions of these transporters are not well understood. One metabolite whose
transport into mitochondria is critical for biosynthesis and proliferation is the amino acid serine. I recently
identified Sideroflexin1 (SFXN1) as the long-sought transporter responsible for serine uptake into mitochondria
in the one-carbon metabolic pathway, which is commonly upregulated in cancer. SFXN1 is part of the
conserved carrier family of Sideroflexins consisting of five homologues in mammals. All Sideroflexins localize
to mitochondria but vary in their tissue expression patterns and their functions in vivo are unknown. My
preliminary data suggest that Sideroflexins, including SFXN1, have other physiologically relevant substrates
beside serine, such as alanine and cysteine, and play important roles in metabolism outside of the one-carbon
pathway. While SFXN1 and its closest homologue, SFXN3, are functionally redundant, other Sideroflexins can
compensate for loss of SFXN1 to varying degrees suggesting a difference in substrate specificities and/or
affinities. The most distant homologue, SFXN4, has a function outside of one-carbon metabolism and likely
does not transport serine. I hypothesize that since SFXN4 is required for TCA cycle flux and mitochondrial
respiration, it is responsible for the uptake of another metabolite with a key role in mitochondrial metabolism,
such as glutamine. To broadly identify SFXN1 and SFXN4 candidate substrates, I will use untargeted
metabolomics methods and determine whether transport of these substrates occurs in vitro and in cells. I will
use Seahorse extracellular flux analysis to determine which respiratory chain complex and thus which electron
donor is affected by loss of SFXN4 and perform a negative selection CRISPR screen to probe SFXN4 function
in an unbiased way. Finally, I will determine the physiological functions of Sideroflexins using knockout mice.
By elucidating the functions of Sideroflexins, an important but largely unstudied family of potentially
chemotherapeutically relevant mitochondrial transporters, my research will shed light on the poorly understood
role of mitochondrial transport in cellular metabolism and in physiology.

Public health relevance
8. PROJECT NARRATIVE Alterations in cellular metabolism underlie important human diseases including cancer and diabetes, with mitochondria playing a key role being responsible for generating both energy and precursors for biosynthesis. Mitochondrial transporters facilitating metabolite exchange between mitochondria and the cytosol direct metabolite flux in the cell but remain poorly understood despite their critical role in cellular metabolism, organismal physiology and disease. This research seeks to identify substrates and functions of the Sideroflexins, a largely unstudied family of mitochondrial transporters, and thus will shed light on the mechanisms underlying the flux of metabolic precursors within the cell, and importantly, could lead to new targets for chemotherapy.